Advanced Voltage Indicators Tailored for Two-Photon Resonant Scanning Applications

SUMMARY
Understanding brain function requires tools capable of recording membrane voltage with high spatial and
temporal resolution, cell-type specificity, and compatibility with animal models. Genetically encoded voltage
indicators (GEVIs), protein-based fluorescent biosensors of membrane potential, have the potential to achieve
these specifications and enable optical measurements voltage dynamics in the brain. This project focuses on
developing next-generation GEVIs optimized for two-photon (2P) microscopy, the gold standard for deep-tissue
imaging in scattering brain tissues. Specifically, we aim to improve GEVI sensitivity for detecting subthreshold
signals and enhance response kinetics to reliably capture rapid action potentials in awake, behaving animals. A
key objective is to tune indicators for maximal performance when using resonant scanning microscopy, the most
widely accessible two-photon imaging method.
Key innovations include refining our high-throughput screening platform to identify fast-kinetics GEVI variants,
engineering ultrasensitive GEVIs tailored for synaptic activity, and designing advanced subcellular targeting
strategies to minimize background fluorescence. These efforts will incorporate directed evolution, synthetic
dosage compensation circuits, and clustering strategies to enhance signal-to-noise ratios. Preliminary data
demonstrate substantial advancements in GEVI sensitivity and voltage response dynamics, including new
mutations that improve fluorescence changes across a broad voltage range.
The optimized GEVIs will undergo rigorous validation in vitro and in vivo, combining state-of-the-art
electrophysiology and 2P microscopy to benchmark their performance against existing tools. By addressing
current limitations in GEVI technology, this project aims to expand the utility of voltage imaging, providing
neuroscience researchers with powerful tools to explore neural computations, synaptic integration, and their
disruption in neurological disorders. These innovations are expected to catalyze widespread adoption of GEVIs,
advancing our understanding of brain function in health and disease

Public health relevance
PROJECT NARRATIVE Genetically encoded voltage indicators (GEVIs) are cutting-edge biosensors that allow scientists to non-invasively monitor electrical activity in living tissues, enabling the study of brain function, from normal cognitive processes to the mechanisms underlying neurological disorders. This project seeks to develop next-generation GEVIs specifically optimized for widely accessible resonant scanning two-photon microscopes, making these powerful tools more practical for researchers worldwide. By combining advanced biosensor engineering, enhancements to automated screening technologies, and innovative methods for precisely targeting indicators to brain cells, the team aims to expand the use of GEVIs and unlock new possibilities for brain research.